RCMI Center for Cancer and Health Disparities Research

SUMMARY – OVERALL
To sustain Xavier’s overall research momentum and advance to the next level of excellence in cancer and health
disparities research, the RCMI Cancer and Health Disparities Research Center will implement program activities
to support early stage, underrepresented investigators, enhance core facilities to support Xavier researchers,
and promote long-lasting, bidirectional partnerships between Xavier and local communities to address health
disparity issues. The RCMI Center will consist of three research projects in basic biomedical, behavioral, and
clinical research and four Cores: The Administrative Core, the Investigator Development Core, the Research
Capacity Core, and the Community Engagement Core. These programs will be implemented to achieve the
following specific aims: Aim 1. Enhance Xavier’s research capacity for basic biomedical, behavioral, and clinical
research. The RCMI program will maintain, strengthen and optimize core services in support of Xavier
investigators. Core facilities will be restructured, consolidated, and operations will be streamlined to maximize
productivity and efficiency of Xavier’s ongoing research projects. Aim 2. Enable Xavier investigators to become
more competitive in obtaining external funding. This will be achieved by a) supporting three research projects in
three areas encompassing basic biomedical, behavioral, and clinical research to enable these project PIs to
become competitive in R01 applications; b) providing critical research resources for research projects through
the Research Capacity Core; c) providing, through the Investigator Development Core, pilot funding to obtain
necessary preliminary data and/or data analyses for the development of fundable research proposals; and d)
providing grantsmanship training through grant writing workshops and professional review services. Aim 3.
Promote career enhancement of Xavier’s early-stage investigators through a Research Development Network
supporting new faculty for five years to obtain extramural funding. Aim 4. Enhance the quality and dissemination
of research on minority health and health disparities. We will organize semi-annual symposiums and workshops
on the quality of health disparities research to offer training in good scientific practices, appropriate statistical
usage, and responsible laboratory practices for researchers at all levels. Aim 5. Expand sustainable relationships
with community-based organizations that will partner with Xavier researchers. A Community Engagement Core
will be enhanced to a) promote and sustain community-academic partnerships through bidirectional knowledge
sharing on intervention strategies and scientific discovery in health disparities; b) facilitate greater community
involvement in setting research priorities and creating more opportunities for academic-practitioner-community
research partnerships; c) build capacity (knowledge and skills) among research investigators, community
members, health systems, and potential research participants to conduct innovative and transformative research
that addresses community health needs; d) provide support for investigators to better disseminate research
findings to the scientific community, community organizations, and lay communities.

Public health relevance
Overall RCMI Narrative The RCMI Cancer and Health Disparities Research Center at Xavier University of Louisiana will build research capacity to support early stage, underrepresented investigators to conduct high- quality and impactful research on minority health and health disparities, especially in the area of cancer. The RCMI will be a multi-component center that includes a comprehensive research capacity core to provide the most needed data science and technology tools for Xavier investigators, an investigator development core to better prepare our early stage investigators for research success in competitive extramural support, particularly from NIH, and a community engagement core to promote research on minority health and health disparities and strengthen sustainable partnerships with community based programs in low income, minority neighborhoods.